Administrative Core

The sharing of strengths encouraged by the Program Project funding mechanism provides for greater opportunities and capabilities through the unification of a shared commitment to a central hypothetical question than would exist for any of the scientists involved in the Proposal individually. The main goal of the Administrative Core of this Proposal is to facilitate and support the unification and interaction of the scientists and administrative personnel working on the four Projects and two Cores from The Rockefeller University and Yale University that comprise this Proposal. Specific Aims. Aim I. Coordination and communication between the Cores and Projects in the Proposal Facilitate communication between the four Projects, two Cores and two institutions Schedule all formal meetings Facilitate the transfer of information for data sharing and manuscript generation Career development coordination center for students and postdoctoral trainees Aim II. Maintenance of the Physical Working Space, Supplies and Equipment for the Scientific Core and Projects I, II and IV of the Proposal Maintenance of the physical laboratory and administrative space at Rockefeller Oversight of the laboratory safety guidelines Purchase of and maintenance of supply stocks Aim III. Data and Progress Record Maintenance and Clerical Support for the Proposal Clerical support and record maintenance Maintenance of project-generated resources files Publication generation and archive for the Proposal Supply and equipment record maintenance for the Scientific Core and Projects I, II and IV Budget tracking and allocation for the Cores and Projects Data Sharing, Biological material resources and tools generated by the Program Project Grant